IGF 1 WITH GH, INSULIN, AND AMINO ACIDS IN REGULATION OF HUMAN MUSCLE METABOLISM

This research examines the interactions of insulin-like growth factor-1 (IGF-1) with growth hormone, amino acids, and insulin on human skeletal muscle protein metabolism. After baseline measurements, IGF-1 will be infused intraarterially and GH or amino acids added systemically. In a separate study, insulin will be co-infused with IGF-1. Repeat measurements will be made after 3 and 6 hours of infusions.